Accurate prediction of neutralization capacity from deep mining of SARS-CoV-2 serology

ABSTRACT The goal of this project is to establish an accurate and sensitive method for predicting the neutralization capacity against SARS-CoV-2 of serum samples by deep mining of antibody profiles. The COVID-19 pandemic remains a global threat with nearly seven million cases and 400K deaths. In the absence of effective vaccines and therapeutics, immunity against SARS-CoV-2 is a main mechanism of protection against SARS-CoV-2 (re)infection. Our recent studies of convalescent serum samples revealed that their levels of neutralization capacity vary greatly (over 100-fold) and only a small subset has high neutralization capacity. Because viral neutralization assays are inherently low throughput, it is unrealistic to apply it to a high-risk population such as hospital workers in a timely manner. Unfortunately, there is only moderate correlation between the neutralization capacity and the level of anti-SARS-CoV-2 antibody levels determined using standard ELISA. Clearly, we still do not understand what types of antibodies contribute to viral neutralization. Our overarching hypothesis to be tested in this project is that by examining the antibody profile in patient serum more deeply and quantitatively in terms of antigens, epitopes and antibody types, we will be able to identify quantitative predictive markers for viral neutralization. To this end, we will develop multiplex assay for SARS-CoV-2 serology that will enable us to deeply characterize the antibody profile. We will then develop a predictive algorithm by utilizing. We have assembled a team of experts with truly complementary skills in antibody characterization, virology and data mining. We have access to a large number of convalescent serum samples, which will enable us to critically validate our technology. We will expeditiously execute the following aims. (1) We will develop multiplex serology assay for SARS-CoV-2 that can profile up to 15 antibody-antigen interactions in a single reaction. The main technical innovation is the introduction of multi-dimensional flow cytometry. We will produce multiple antigens including Spike, receptor-binding domain and nucleocapsid protein, and their natural and designed variants. We will refine and validate the assay using a large panel of convalescent serum samples. (2) We will develop an improved viral neutralization assay to better quantify the neutralization capacity. (3) We will develop a predictive algorithm for neutralization capacity that utilizes the antibody profiles from our multiplex assay. This analysis will identify serology parameters that contribute to neutralization. The end products of this project will include a high-throughput serology assay that gives far- richer antibody profiles than the current standard accompanied with an accurate predictive algorithm. Together, this platform will help advance a fundamental understanding of SARS-CoV-2 infection as well as the development of vaccines and therapeutics against this formidable pathogen.

Public health relevance
PROJECT NARRATIVE The level of anti-SARS-CoV-2 antibodies in blood samples of people exposed to the virus vary greatly, and current antibody testing methods do not accurately determine the level of neutralizing antibodies. This project will develop innovative platform for deep mining of antibody profiles from a small amount of blood samples and accurately predict their neutralization capacity. This technology will help advance our fundamental understanding of SARS-CoV-2 infection and immune responses and the development of vaccines and therapeutics.